MECHANISM OF ACTION OF THE ANTITUMOR DRUG TAXOL

Taxol is a remarkably effective and increasingly widely-used drug for the treatment of cancer. The long-term objective of this proposal is to understand the antitumor mechanism of taxol. The primary targets for taxol are microtubules. Despite considerable knowledge gained in the past several years about how taxol acts, its precise mechanism of antitumor action is far from understood. Recently we discovered that the most potent antiproliferative action of taxol in HeLa cells is arrest of mitotic progression at the metaphase/ anaphase transition that appears to result from suppression of mitotic spindle microtubule dynamics. Thus the specific aims of this proposal are the following: 1) To characterize the effects of taxol on microtubule dynamics in living cells. The effects of taxol on microtubule dynamics will be examined by video microscopy of individual rhodamine-labeled microtubules in living cells. In addition, the dynamics of mitotic spindle microtubules attached to chromosomes will be analyzed by video microscopy using a transfectable kinetochore marker and by electron microscopy following incorporation of microinjected biotinylated tubulin and colloidal-gold-labeled antibody staining. 2) To examine how taxol blocks mitosis. The effects of taxol on the interactions of microtubules with key spindle components, including quantitation of the number of microtubules attached to kinetochores, will be examined at the ultrastructural level. 3) To examine the role of the beta-tubulin isotype composition of microtubules in determining the sensitivity of tumor cells to taxol. The effects of taxol on microtubule dynamics will be examined by video microscopy of microtubules composed of isotypically-purified bovine brain tubulin as well as microtubules of differential isotype composition isolated from taxol-sensitive and taxol-resistant human leukemia cells. By stably transfecting human tumor cells with cDNAs for selected beta-tubulin isotypes, the effects of altering levels of tubulin isotype expression on the sensitivity or resistance to taxol will be tested. 4) To investigate whether tumor cell killing by taxol is directly related to inhibition of mitotic progression or whether it is related to abnormal exit from mitotic block. The important landmarks of the pathway from taxol -induced slowed mitotic progression to cell death will be investigated by video microscopy of several carefully-chosen human tumor cell lines that encompass a range of taxol-sensitivities. How mitotic block induces cell death will be addressed by experimentally altering the pathway and attempting to rescue the cells from apoptotic cell death. Much of our recent work indicates that a common mechanism, i.e., suppression of microtubule dynamics, underlies the actions of many antimitotic drugs. It is important for the clinical use of taxol and for rational design of new drugs that act by kinetic suppression of microtubule dynamics to understand precisely how taxol works at the molecular level. Understanding the linkage between microtubule dynamics, mitotic block, resistance to taxol, and cell death promises to lead to new drug targets, combinations, and schedules of administration that will improve the efficacy of chemotherapy.